Mechanisms underlying dampened ischemic tolerance in type 2 diabetes

Tolerance to cerebral ischemia can be induced by exposure to brief ischemia or
pharmacological agents including the Toll-like receptor (TLR) agonists, a phenomenon known
as the ischemic preconditioning (IPC). Established evidence suggests that innate immune
pathways such as TLRs and type 1 interferon (IFN) signaling are involved in IPC-mediated
neuroprotection. Although it is well known that tolerance to ischemia or the effect of IPC
declines with age and pathological conditions including metabolic diseases, the underlying
mechanism for this damping effect is not well understood. Using single cell RNA sequencing,
we have recently found that monocytes in the peripheral blood of T2DM mice db/db are
defective in type 1 and type 2 IFN signaling pathways, rendering them incapable of producing
interferon stimulus genes (ISGs) that are known to be immunomodulatory and anti-
inflammatory. Given the premise of the defective IFN responses in the db/db mice, we
hypothesize that they should show attenuated tolerance against cerebral ischemia following
TLR-mediated preconditioning compared to db/+ mice. To test hypothesis, we will compare the
effect of preconditioning with TLR agonists CpG or LPS in T2DM and control mice subjected to
MCAO by stroke outcome, blood flow imaging, coagulation. We will determine the effect of TLR-
mediated preconditioning on leukocyte trafficking to the meninges and brain parenchyma by
comparing phenotypes and transcriptome profile of leukocytes in each compartment. We will
also determine how the altered native immune responses in db/db mice predispose them to post
stroke immunosuppression and exacerbated vascular damage and BBB leakage compared to
control mice. The knowledge gained in this study will be insightful in identifying potential
therapeutic targets to circumvent age and metabolic disease-associated decline in ischemic
tolerance in multiple organs.

Public health relevance
Tolerance to ischemia can be induced by various methods or drugs nowadays to minimize damage to organs that are deprived of blood supply. However, our ability in developing resistance to ischemia declines with age and metabolic diseases. The goal of this project is to determine the molecular mechanisms underlying the failed tolerance to stroke in type 2 diabetes. Data from our research suggest that this failure is closed linked to the modified immune response and chronic inflammation in subjects with type 2 diabetes. This proposed project will characterize these changes in order to find therapy to correct this condition.